Analytical Cell Models Core

Analytical Cell Models Core - Abstract
The DDRCC Analytical Cell Models Core proposes to provide DDRCC members with access to state-of-the-art
tissue culture models of digestive and liver disease. We will use genome engineering technologies including
CRIPSR-Cas9 to introduce genetic alterations into established cell lines and into induced pluripotent stem cells
(iPSCs). The iPSCs will be differentiated to form cells of the gastrointestinal tract and liver that will be used for
study by DDRCC members. The Core will also provide members with primary parenchymal and non-
parenchymal livers cells from both human and rodent livers as well as critical tools for the analyses of cells. In
addition to providing DDRCC members with cell lines that can be used for direct analyses, the Core will also
provide members with training and critical reagents that will allow them to establish many of the procedures in
their own laboratories. The Core will adopt a program of rigorous evaluation that will ensure that it performs
optimally and continues to provide DDRCC members access to new technologies as they are developed. Dr.
Duncan, who will lead the core, is an expert in stem cell biology and cell differentiation, and he has used genome
engineering extensively to generate cells to model liver disease. He has previous experience in running a similar
core while a Professor at the Medical College of Wisconsin. He will be supported by Dr. Don Rockey who has
extensive experience in the isolation of cells from both human and rodent livers.